Evaluation and use of 2D and 3D HepaRG cells to screen for chemical toxicity

The overall goal of this project is to further validate and refine study design for the selection of 2D and 3D HepaRG cells and spheroids, as model systems in the screening and prioritization of chemicals for test at the Division of Translational Toxicology.
Keywords: HepaRG, primary human hepatocytes, PHH